Augmented mapping of the Extreme Heat and Cold Events (EHE/ECE) at continental scale with cloud-based computing

Project Summary/Narrative
Extreme heat and cold events (EHE/ECE) have been linked to a range of adverse health outcomes from
exacerbated pre-existing conditions to mental illness and respiratory and cardiovascular disease Previous
research has often determined the areas and population impacted by EHE/ECE through simplistic methods
that assign temperature data from the closest weather station to the population being studied (e.g., a census
tract or postal zipcode). Our preliminary analysis has demonstrated that dynamic spatial-temporal
methodologies significantly alleviate misclassifications that tend to occur in conventional approaches.
Implementing more sophisticated models with higher spatial and temporal resolution can pose computational
complexity which hinders application and scalability of the dynamic models. Here we propose a hybrid method
to leverage cloud computing resources to streamline and scale up EHE/ECE identification workflows with
improved specification to help configuration of on-premises computing. Aim 1: Improving scalability and
computational efficiency of detecting extreme climate events in-cloud versus on-premises computing We will
develop and implement computational methodologies to (1) scale up the spatial interpolation methods at
continental scale using parallel and distributed computing algorithms, (2) monitor and assess the performance
of these algorithms in terms of computational time, memory allocation and storage resources compared to the
dedicated server utilization and conventional High-Performance Computing (HPC) approach.We hypothesize
that cloud computing will improve efficiency of current methods which have been implemented on on-premises
computing infrastructure using all-in memory solutions and serialized data pipeline. We will leverage
efficiencies of spatially enabled databases along with DevOps tools and services such as containerization, and
automated deployment to streamline our research workflows. Aim 2: Improving accuracy and robustness of
extreme climate events identification in-cloud versus on-premises computing We will assess the robustness of
dynamic EHE/ECE delineation methods when applied to heterogeneous climatological data at continental
geographies and beyond. Specifically, we will evaluate the extent to which cloud computing improves the
accuracy of the spatial-temporal methods in identifying populations and areas impacted by EHE/ECE using
different model parameterization scenarios. We hypothesize that cloud computing will improve the accuracy
and robustness of EHE/ECE identification methods by (1) facilitating development of more complex models
that take into account additional environmental variables, (2) by streamlining reproducibility practices that
enables the wider scientific community to test and validate the models at multiple scales that results in more
reliable models

Public health relevance
Project Narrative This supplement to parent grant RF1AG074372 will develop computational approaches to compare cloud versus on-premises computing for the identification of extreme weather events in the United States. The parent grant aims to generate evidence regarding the immediate, short-, and long-term effects of exposure to extreme heat or cold weather events on the health and livelihood of American seniors living with Alzheimer's disease or Alzheimer's disease-related dementia by mapping weather events onto patient cohort data. The tools evaluated in this supplement will enable the mapping of extreme events to patient cohort data to evaluate the degree to which the extreme events exacerbate or cause complications the older AD/ADRD patient populations.